Vaccine and radiation for the therapy of human cancers

We have determined that the use of low doses of external beam radiation, insufficient to kill tumors, will alter those tumor cells to render them more susceptible to T-cell-mediated lysis. We have shown in murine models that irradiation of a primary tumor could facilitate systemic anti-tumor activity by engaging the lytic capacity of vaccine induced antigen specific CD8 T-cells and promoting cross priming of additional T-cell populations which mediated regression of distal metastatic tumors (abscopal effect). Employing a panel of human tumor cells in-vitro, we have examined the mechanism of immunogenic modulation and determined that radiation modulated components of the endogenous antigen-processing chain and induced certain surface molecules resulting in increased MHC-peptide loading and subsequent T-cell recognition and killing. Radiation was additionally shown to upregulate the tumor surface expression of monoclonal antibody targets (Her2/Neu, EGFR, CD20) culminating in increased tumor killing by NK cells via ADCC. We have now shown that the immunogenic modulation signature of external-beam radiation (photon) is similar to that induced by emerging heavy particle radiation; proton beam and the alpha-emitting radionuclide radium-223. These findings offer a rationale for the use of radiation in combination with immunotherapy, including for patients who have limited treatment options (such as chordoma